Regulation of Hippocampal Neurogenesis and Behavior by Noggin

Hippocampus (HIP)-dependent cognition is regulated by a variety of different types of environmental stimuli,
but the mechanisms by which the environment initiates and/or modulates behavior are not fully understood.
Adult inbred mice display wide variability in performance on HIP-dependent cognitive tasks, and there is
highly significant negative correlation between levels of endogenous BMP signaling in the HIP and baseline
cognitive performance. Further, exposure to exercise or environmental enrichment increases expression of
the BMP-inhibitor, noggin, in the HIP and attenuates BMP signaling concurrent with enhanced cognitive
performance and increased neurogenesis. Similarly, antidepressants increase neurogenesis in association
with behavioral changes, and these changes are mediated by an increase in noggin expression and a
reduction in BMP signaling in the ventral hippocampus. Reducing BMP signaling in adult mice by ventricular
infusion, transgenic overexpression, or viral overexpression of noggin in the HIP reproduces many effects of
exercise on cognitive and affective behavior and on neurogenesis. In the HIP, noggin is localized within
dentate granule neurons (GC),and membrane depolarization promotes noggin release from cultured GC.
Sonic hedgehog signaling promotes even greater levels of release of noggin by cultured GC. Disruption of
cilia (IFT88 knockout) or inhibition of transport to cilia (Rab8a/b knockdown) depletes noggin from cultured
GC. In toto these observations suggest that BMP signaling plays a central role in regulating both
neurogenesis and HIP-dependent behavior, that BMP signaling is regulated by activity-dependent release of
noggin by GC, and that cilia regulate noggin expression and release by GC. This proposal will test the
hypotheses that:
1) Release of noggin by dentate gyrus GC is a crucial link between environmental stimuli and both cellular
changes in the hippocampal neurogenic niche, and hippocampus-dependent behavior.
2) Environmental signals transduced through primary cilia and neuronal activity cooperatively regulate
expression and release of noggin to regulate neural progenitor proliferation.
3) The DG circuitry is structured to support the transfer of information between largely parallel cortical and
subcortical systems via interactions between mature and immature neurons. Activity-dependent release of
noggin alters this functional connectivity leading to changes in hippocampus-dependent behavior.

Public health relevance
The continued generation of new neurons in a region of the brain known as the hippocampus is involved in regulating various types of cognitive behavior. We have found that noggin, a molecule that modulates a specific signaling system in the brain, regulates neurogenesis and behavior. The proposed studies seek to understand how noggin works in the brain with a long- term goal of defining specific targets for drug treatment that may help to maintain normal cognitive function.